Evaluating the Implementation and Impact of the Updated Relationship Health and Safety Screening National Rollout

Intimate partner violence (IPV) is a complex public health crisis with far-reaching consequences for Veterans
and their families. The healthcare system plays an integral role in the detection and treatment of IPV through
implementation of IPV screening and provision of resources in response to IPV disclosures. The National IPV
Assistance Program (IPVAP) is in the process of expanding the screening directive from women and at-risk
Veterans to a national rollout and updated directive indicating that Veterans of all genders are to be screened
annually for IPV using the Relationship Health and Safety (RHS 3.0) screener. Evaluating the implementation
and impact of this updated national screening rollout is a critical priority for IPVAP. Prior HSR&D funded
research has focused on identifying barriers and facilitators of implementing IPV screening among women of
reproductive age in primary care settings. However, little is known about the implementation or clinical impact
of screening patients of all genders and ages for IPV. The proposed study builds on past findings by evaluating
the national rollout expanding IPV screening to all Veterans. IPVAP’s updated directive requires foundational
screening implementation and outcome data among non-women Veterans and the development of data
tracking and systems. Additionally, a critical missing piece needed to inform scale-up of IPV screening to all
Veterans is data on the impact of IPV screening through identification of patient outcomes following IPV
disclosures. A robust partnered evaluation of the expanded IPV screening national rollout will extend prior work
and assist IPVAP in determining implementation and clinical impact outcomes. We plan to simultaneously
evaluate the rollout of IPVAP’s expanded national IPV screening directive now targeting all patients while also
examining the impact of this new initiative to provide innovative and critically needed data on the impact of
screening non-women patients to the Program Office. As a result, we will develop the tools and systems
essential for IPVAP to monitor screening implementation across clinical settings and identify Veteran-focused
outcomes related to IPV screening and positive disclosures, and best practices for scale-up and maintenance
of IPV screening among all Veterans. The specific aims of this PEI are to (1) Evaluate implementation of the
expanded RHS 3.0 screening and response national by (a) assessing IPV screening implementation outcomes
across RE-AIM domains (reach, effectiveness, adoption, implementation, and maintenance); (b) examining
potential differences in outcomes by patient characteristics (e.g., gender, age, race, ethnicity, sexual
orientation, marital status); and (c) identifying clinical settings and provider types most and least likely to
screen for IPV and yield positive IPV disclosures during screening. (2) Identify impact of IPV screening on
patients as well as potential gender differences in impact by (a) examining service utilization and clinical
outcomes following positive IPV disclosures during screening; and (b) understanding experiences of screening
among patients who disclosed IPV during screening encounters. We will use implementation science
frameworks and mixed quantitative and qualitative data to simultaneously evaluate implementation and impact
of IPV screening. The RE-AIM domains and clinical outcomes data following IPV disclosures will be assessed
using data extracted from the Corporate Data Warehouse (CDW) and clinical impact of IPV screening will be
examined through qualitative interviews with Veterans who disclosed IPV experiences during routine
screening. This robust and highly-partnered evaluation will (1) extend prior research conducted primarily with
women Veterans; (2) provide critically needed clinical data to enhance and inform national programming; (3)
result in the development of data systems essential for monitoring screening; and (4) lead to optimization of
future IPV screening implementation strategies.

Public health relevance
The healthcare system plays an integral role in the detection of intimate partner violence (IPV), a complex public health crisis with far-reaching consequences. Although the focus of IPV screening implementation at VHA to date has targeted women Veterans of reproductive age, the national IPV Assistance Program (IPVAP) is expanding IPV screening to Veterans of all genders and ages through a national rollout. Evaluating the implementation and clinical impact of this rollout, with a primary focus on identifying potential gender differences, is a critical priority for IPVAP. This robust and highly-partnered evaluation will (1) extend prior research conducted primarily with women Veterans; (2) provide critically needed clinical data to enhance and inform national programming; (3) result in the development of data systems essential for monitoring screening; and (4) lead to optimization of future IPV screening implementation strategies.